Center for Advanced Imaging Innovation and Research (CAI2R)

Overall Project Summary
The Center for Advanced Imaging Innovation and Research (CAI2R) pursues a mission of bringing people
together to create new ways of seeing. The work of our Center has been focused on creating new paradigms
for the acquisition, reconstruction, and interpretation of biomedical images, and on implementing new
collaboration models in order to translate these developments rapidly into clinical practice.
The world of medical imaging is changing, and CAI2R has been at the forefront of that change. Tasks that
were once the sole domain of meticulously-engineered hardware are increasingly being accomplished in
software, aided by modern AI and informed by diverse arrays of inexpensive auxiliary sensors. The longstanding
conviction that “bigger is better” in imaging technology is being supplanted, or at least supplemented, by a new
“less is more” philosophy. It is a time of remarkable creative flux, with new technologies and new mathematical
transforms causing long-held assumptions about the daily practice of imaging to be called into question. In short,
imaging is in the process of being reimagined. Each of our three Technology Research and Development (TRD)
projects will advance this project of reinvention, introducing new enabling technologies & transforms:
1. Reimagining the Future of Scanning: Intelligent image acquisition, reconstruction, and analysis.
2. Unshackling the Scanners of the Future: From rigid control to flexible sensor-rich navigation.
3. Revealing Microstructure: Biophysical modeling and validation for discovery and clinical care.
Having pioneered the use of machine learning for accelerated image reconstruction, and having introduced
new continuous comprehensive data acquisition methods, we will bring the two together for improved quantitative
imaging. Based on our experience with use of shared information across time in dynamic imaging, we will also
explore new ways to leverage prior information in longitudinal scanning over spans of months rather than
milliseconds. In place of our early technology test beds of ultra-high-field MRI and MR-PET, we will explore new
applications in low-field MRI and MR-guided radiotherapy. We will extend the “standard model” of microstructure
originally conceived by our team, developing newly efficient and information-rich diffusion MRI methods.
Our Center has an explicit translational focus, which is reflected in the day-to-day operation of TRD projects
as well as in the topics of Collaborative Projects (CPs) and Service Projects (SPs), which are focused on three
general areas of high public health impact: cancer, musculoskeletal disease, and neurologic disease.
In keeping with this translational emphasis, CAI2R is also be driven by an embedded collaboration model in
which basic scientists, clinicians, and industry developers sit down together regularly at the scanners for
interactive technology development and assessment. With early involvement of clinical stakeholders and
industry partners, we aim to make CAI2R technologies, software platforms, and datasets widely available, for the
advancement of biomedical knowledge and for the benefit of patients and the physicians who care for them.

Public health relevance
Overall Project Narrative The Center for Advanced Imaging Innovation and Research (CAI2R) develops novel imaging techniques and technologies for the improved diagnosis and management of cancer, musculoskeletal disease, neurological disease and other disorders with a profound impact on human health. Leveraging novel magnetic resonance imaging (MRI) and sensor hardware, together with rigorous biophysical modeling and artificial intelligence, we aim to expand biomedical knowledge and improve the care of patients.